Tracking the hierarchical secretion of ESX-1 substrates through the mycobacterial cell envelope

Project Summary
Mycobacteria, including human pathogens such as Mycobacterium tuberculosis and the non-tuberculous
mycobacterium Mycobacterium marinum, require Type VII ESX secretion systems for optimal growth, survival,
and virulence. Despite being the focus of extensive genetic and biochemical efforts, the mechanism of ESX-
mediated protein secretion, especially through the cell wall, remains elusive. In general, the exploration of
secretion pathways within the cell wall of mycobacteria is constrained by the current limited ability to localize
proteins to specific subcellular compartments. The objective of this exploration is to overcome this obstacle
towards elucidating protein secretion by the ESX-1 system. The rationale is that the tools and the knowledge
gained will allow us to (1) track components of the ESX-1 system to the cell wall and/or cell surface and (2)
thereby test a model for ESX-mediated secretion through the cell envelope by establishing the hierarchy of
export to these subcellular compartments. The innovation of this proposal is to apply cell wall-specific protein
tagging, surface-specific protein detection, and site-specific protein photocrosslinking methods that have not
yet been applied to ESX-1-mediated secretion. Prior research, including initial studies, provide evidence that
these approaches will be successful in achieving the stated goals. The proposed studies are expected to
establish functional and molecular relationships among ESX-1 substrates that determine their transit through
the cell envelope and thereby enable future studies into the detailed mechanism of ESX-1 secretion. These
results are anticipated thereby to advance fundamental knowledge of a unique pathway critical to
mycobacterial pathogenesis.

Public health relevance
Project Narrative The proposed research is relevant to public health because gaining fundamental knowledge about mycobacterial physiology and the processes that contribute to its adaptation and survival are key initial steps in the development of new chemotherapeutics against mycobacterial infections, toward the alleviation of diseases caused by pathogens such as Mycobacterium tuberculosis. This research is relevant to the part of the NIAID mission that supports basic research toward the better understanding, treatment, and prevention of infectious diseases.